Task C16: Production and Development of Schistosomiasis Research Reagents

The purpose of this task order is to maintain and distribute schistosomiasis parasites, snails, and select parasite reagents (difficult to source genomic, molecular, and immunologic) to the research community.